Sensorimotor control of common-goal bimanual coordination

Project Summary
Skilled inter-limb coordination is critically important for performance of many activities of daily living (ADL). In
many patients with neurological disorders, such as stroke and cerebral palsy, impairments in bimanual
coordination are often functionally greater than impairment of the more affected limb. Therefore, improving our
understanding of neural mechanisms underlying bimanual control in typically-developed adults is critically
important as a stepping stone towards creating more effective and targeted clinical interventions. While most of
the existing bimanual research has focused on tasks in which each limb has independent goals, the proposed
research will investigate how the brain controls two limbs when they share a common goal. We will test the
hypothesis that cortical activity, in particular within the posterior parietal cortices (PPC), is differentially
modulated to support common-goal bimanual coordination when the limbs are subjected to variable constraints
and perturbations. We propose a series of experiments in which healthy adults will perform a virtual object
manipulation task with the actions of two limbs. We will systematically vary the symmetry of bimanual actions
in our virtual manipulation task by introducing persistent constraints or abrupt perturbations. These constraints
and perturbation challenge the central nervous system to correctly perform the common-goal bimanual
coordination. We expect greater performance error when the task is performed with constraints or
perturbations applied to one limb (asymmetric) than both limbs (symmetric). Therefore, this experimental
paradigm will enable us to quantify the behavioral changes of spatial-temporal inter-limb coordination in
response to these constraints and perturbations, and investigate the underlying cortical activities using
electroencephalography (EEG). Moreover, we will determine the causal role of bilateral intraparietal sulci (IPS)
in bimanual common-goal coordination using transcranial magnetic stimulation (TMS) as a system
identification tool to induce reversible virtual lesions. We will deliver continuous theta burst TMS or high
intensity single pulse stimulation to medial IPS or a control region (i.e., anterior IPS) of either right or left
cerebral hemispheres, and quantify the resulting deficit in bimanual coordination. Our findings have potential
applications to translational research on sensorimotor rehabilitation to improve bimanual training paradigms in
stroke bilateral therapies (i.e., common-goal coordination), and guide the design of non-invasive brain
stimulation to enhance the outcome of these interventions. Our long-term goals are to (1) extend the
investigation of neural control of common-goal inter-limb coordination to a broader cortical network by
combining our unique experimental paradigm with functional magnetic resonance imaging, and (2) apply our
experimental approach to study coordination of bimanual movements in individuals affected by sensorimotor
deficits to design evidence-based, user-centered interventions.

Public health relevance
Project Narrative Skilled bimanual coordination is an important component of a wide range of activities of daily living. The proposed project aims at determining the neural mechanisms underlying the control of bimanual coordination when two limbs share a common goal. The knowledge gained in this project can provide significant insight to improve the effectiveness of motor rehabilitation interventions for restoring upper-limb function in individuals affected by neurological disorders.